ANALYSIS OF SUBCELLULAR DISTRIBUTION OF PHYTOCHROMES

Numerous experimental approaches have provided information about the subcellular distribution of phytochromes. With rare exception the assays depend ultimately upon either spectrophotornetric or immunochernical detection to verify the presence of a phytochrome species within a particular cellular compartment. The interpretation of these results is ambiguous at best. We propose to investigate the localization of various phytochromes through the fluorescence emission generated by excitation of a phytochrome-green-fluorescent protein fusion protein. It is our hope that multi-photon microscopy will allow for a real time analysis of phytochrome localization which can be correlated with the physiological role for thit protein.